Dissecting cis regulation of gene expression in schizophrenia.

PROJECT SUMMARY
Our understanding of the genetics of schizophrenia is advancing at a rapid pace and an increasing number of
risk-­associated polymorphisms and variants have been discovered. Because the majority of these variants
reside in intergenic, intronic and other non-­coding sequences, a precise variant or target gene for
schizophrenia has not been identified. Therefore, a major challenge lies in designing testable hypotheses to
elucidate the potential function of disease-­associated non-­coding DNA. Many of the risk variants are thought to
affect gene expression through alterations of regulatory elements, including long-­range enhancer sequences
physically interacting with transcription start sites separated along the linear genome of DNA. The aim of this
proposal is to map the regulatory sequences (or open chromatin) in discrete cellular populations (neurons and
glia) derived from two human cortical brain regions in a large cohort of cases with schizophrenia and controls,
followed by generation of a high-­resolution quantitative trait loci (QTL) map of regulatory sequences. In
addition, high resolution expression quantitative trait loci (eQTLs), mapped in the same samples and brain
regions, will be leveraged to identify schizophrenia associated non-­coding regions that are simultaneously
associated with differential exposure of regulatory regions (open chromatin) and gene expression of nearby
genes (eQTLs). Long-­range enhancer-­promoter interactions of genes potentially regulated by open chromatin
sequences will be mapped in human postmortem brain tissue using chromosome conformation capture. Using
the existing schizophrenia-­related large-­scale molecular data and the high-­impact, high-­resolution,
complementary datasets generated through the proposed studies, we will develop multiscale network models
causally linked to schizophrenia. The action of individual genes on molecular and cellular schizophrenia-­
associated processes and the molecular networks identified in our studies will be validated using iPS-­cell-­
derived cultures of human neuronal cell systems. The multidimensional approach presented here provides a
roadmap to place schizophrenia genetic risk variants in molecular contexts to help identify the underlying
regulatory and expression mechanisms through which they act.

Public health relevance
PROJECT NARRATIVE The VHA Independent Budget Report for FY2003 listed 104,593 Veterans being treated for schizophrenia, accounting for nearly 12% of the VA’s total healthcare costs. Multiscale network models causally linked to schizophrenia will be developed based on existing schizophrenia-related large-scale molecular data and the high-resolution complementary epigenome datasets generated through the proposed work. We will explore functional chromatin loopings at risk-associated DNA variants and polymorphisms in brain tissue and use neuronal cells grown in culture from reprogrammed skin cells to validate the molecular networks predicted to drive schizophrenia. This holds the potential for direct translational and clinical applications of which may reinvigorate stalled drug development that can improve the mental health of our Veterans.